Mentoring in prevention of healthcare-associated infections and antibiotic resistance

The applicant, Dr. Aaron Milstone, is a Pediatric Infectious Diseases Physician and
Epidemiologist who has focused his career on the prevention of antibiotic resistance and
healthcare-associated infections. The current proposal is a competitive renewal of a previously
funded K24 award during which the applicant successfully mentored four junior faculty to
receive NIH career development awards in patient-oriented research. Dr. Milstone is a highly
productive clinical researcher with more than 200 manuscripts, more than 95 first-authored by
his mentees. He has had continuous federal-funding since 2009 to support his research
program translating laboratory and epidemiologic observations into patient- and population-level
interventions. He is sought after as a collaborator and mentor. Dr. Milstone will continue to
leverage the extensive training resources at Johns Hopkins University to recruit and support
trainees. Renewal of this K24 is critical to his desire to continue to mentor young investigators in
the areas of antibiotic-resistance and infection prevention and to continue to evolve his
research. Dr. Milstone will pursue additional training to expand his research program. The
proposed novel research will further advance the field in preventing antibiotic resistance and
healthcare-associated infections in three areas: 1) bacterial culture stewardship to reduce
antibiotic use and resistance, 2) targeting the nasal microbiome to reduce S. aureus nasal
colonization and infection, and 3) identify and address drivers of inequities in pediatric
healthcare associated infections. The proposed projects will build on collaborations in
implementation science, microbiome, and health equity, expand the Dr. Milstone's knowledge in
these areas, and make him a more effective PI and patient-oriented research mentor.

Public health relevance
Antibiotic resistance and healthcare-associated infections are major threats to human health and are a top public health priority. This proposal will support mentoring of the next generation of investigators who will advance the science of infection prevention and protect vulnerable populations, including children, from the impact of emerging antibiotic resistance.